Efficacy and Mechanisms of Resistance to Neoadjuvant Intensive Androgen Signaling Inhibition

PROJECT SUMMARY – PROJECT 1
Localized high-risk prostate cancer (PCa) comprises ~15% of newly diagnosed localized PCa, and the cure rate
for these tumors after primary surgical treatment by radical prostatectomy (RP) is low, with recurrent disease in
up to ~50%. Neoadjuvant trials for these localized high-risk PCa may provide valuable opportunities to increase
cure rates and our understanding of response and resistance. However, previous studies of neoadjuvant
androgen deprivation using GnRH agonists alone have generally shown infrequent pathological complete
responses (pCRs) and have not shown evidence of clinical efficacy. We have hypothesized that responses to
neoadjuvant ADT have been limited due to substantial residual androgen in the prostate, and that more intensive
neoadjuvant androgen signaling inhibition (ASI) therapy, in addition to increasing pCR rates, will translate into
an improvement in disease free survival (DFS) and ultimately overall survival (OS). We have been testing this
hypothesis in a series of phase 2 trials examining the efficacy of neoadjuvant intensive ASI using leuprolide in
combination with abiraterone (ABI) and/or enzalutamide (ENZ) or apalutamide (APA) for 6 months prior to radical
prostatectomy (RP). Responses appear to be improved relative to previous neoadjuvant trials, but it remains
unclear whether the cases with pCR/MRD reflect tumors that have less metastatic potential. Moreover, the
molecular basis for residual disease in prostate, and its relationship to metastatic disease in patients who
progress, remain to be determined. To address the genomic basis of response versus resistance, we propose
comprehensive genomic analyses of tumors with exceptional responses (pCR/MRD) to intensive neoadjuvant
ASI therapy, and of residual disease in RP specimens in men who do not achieve pCR/MRD (Aim 1). These
studies will leverage samples from our previous trials, as well as a large multicenter phase 3 study of neoadjuvant
GnRH agonist/antagonist combined with APA in comparison with GnRH agonist/antagonist alone (PROTEUS
trial, supported by Janssen, NCT03767244). Aim 2 will identify actionable acute nongenomic adaptations that
mediate initial resistance to intensive ASI therapy, and specifically test the hypothesis that these adaptations
converge on expression of D cyclins and activation of CDK4/6 to drive proliferation. Aim 3 is a randomized phase
2 trial of intensive ASI (leuprolide plus darolutamide), alone or in combination with the CDK4/6 inhibitor
abemaciclib. Our long-term goal is to establish neoadjuvant trials as a platform for assessing the efficacy of novel
combination therapies in castration-sensitive PCa.

Public health relevance
PROJECT NARRATIVE – PROJECT 1 We propose comprehensive molecular analyses of responding and resistant tumors in a series of neoadjuvant clinical trials of intensive androgen signaling inhibition (ASI) in men with localized high-risk primary prostate cancer. Moreover, we will test the hypothesis that CDK4/6 activation is driving resistance by conducting a phase 2 clinical trial of neoadjuvant intensive ASI (leuprolide plus darolutamide) combined a CDK4/6 inhibitor (abemaciclib).These studies have important biomarker implications for the selection of patients most likely to benefit from intensive ASI, and for determination of mechanisms of resistance, with additional implications for metastatic castration-sensitive prostate cancer.